Mesolimbic adaptations underlying altered reward sensitivity in neuropathic pain

PROJECT SUMMARY
Chronic neuropathic pain (CNP) is characterized by emotional-affective symptoms, which afflict between 27-
75% of patients and are associated greater pain intensity, reduce compliance with pain management
interventions and drive reduced quality of life in CPN patients. Despite this, there are no effective therapies for
depression symptoms of chronic pain, and these symptoms do not respond to classical antidepressant
therapies. Neuroimaging studies have shown blunted accumbal dopamine release in response to reward in
chronic pain patients, prompting the hypothesis that a hypodopaminergic state underlies affective symptoms in
chronic pain. However, direct evidence for the involvement of altered dopaminergic function in CNP is
contradictory; and the precise mechanisms underlying the emergence of a hypodopaminergic state remain
unknown, preventing the development of targeted therapies for its reversal. Our long-term goal is to inform
novel pharmacological or neuromodulation therapies to treat affective symptoms of CNP. To this end,
we must first understand whether altered function of dopamine neurons drives changes in reward-related
behavior in CNP, as well as the cellular and circuit mechanisms underlying this altered function. To this end,
we will first quantify changes in dopamine release in the nucleus accumbens core (NAcC) across the
development of CNP. We will take advantage of novel optical approaches to longitudinally quantify changes in
tonic and reward-evoked NAcC dopamine release in the same animals over the acute to chronic pain transition
(Aim 1). We will then use patch-clamp electrophysiology with intersectional genetic labeling to record from
NAcC-projecting dopamine neurons at acute- and chronic- timepoints following nerve injury to characterize the
cellular mechanisms by which dopamine dysfunction is instantiated in CNP, which will ultimately be necessary
to design therapies to reverse this dysfunction (Aim 2). Finally, we will determine the role of NAcC-projecting
dopamine neurons in altered reward-related behavior in CNP. We will track behavior for consecutive weeks
with operant tasks designed to capture RDoC-defined behavioral constructs relevant to depression symptoms.
This longitudinal design will establish a high-resolution profile of altered reward valuation and sensitivity across
the transition to CNP and will establish causal links between NAcC-projecting dopamine neuron adaptations
and the emergence of behavioral changes (Aim 3). How adaptations within the mesolimbic dopamine system
evolve over the transition from acute to chronic pain, and whether these adaptations drive affective symptoms
in CNP is unknown. Our proposal will fill this gap by applying novel approaches to probe dopamine neuron
function in vivo and ex vivo over the transition over acute to chronic phases post- nerve injury. It will also lay
the foundation to reverse these adaptations as a therapeutic strategy for affective symptoms of CNP.

Public health relevance
PROJECT NARRATIVE Symptoms of depression afflict between 27-75% of patients with chronic neuropathic pain; these symptoms are associated with greater pain intensity, reduce compliance with pain management interventions and drive reduced quality of life in patients. Despite this, there are no effective therapies for depression symptoms of chronic pain, and these symptoms do not respond to classical antidepressant therapies. In this proposal, we will elucidate how adaptations in the mesolimbic dopamine system drive depression symptoms in a model of chronic neuropathic pain, which is critical for developing novel molecular targets for treating these symptoms and ultimately for improving lives of patients with chronic neuropathic pain.